Coordination of alternative exon and 3'UTR choices in mRNAs

PROJECT SUMMARY/ABSTRACT
With the advent of long-read RNA sequencing technology, there is now the opportunity to quantify how
disparate alternative mRNA termini choices and internal exon choices are combined in full-length mRNAs.
Recent evidence indicates coordinated interactions between alternative termini and exon choices in various
organisms and developmental contexts, rather than random combinations. In Drosophila, individual genes
have been found to exhibit tight coordination of both alternative first exons and alternative internal exons with
alternative 3’UTRs. This project will investigate the role of cell type in coordinating these RNA processing
events. A novel long read sequencing approach will be developed (scPL-Seq) that will permit the quantification
and mechanistic interrogation of coordinated RNA processing events at the single-cell level during Drosophila
neurodevelopment. The regulatory factors that coordinate these RNA processing events in specific cell types
will be identified. In Drosophila, we previously demonstrated for the Dscam1 gene that coordination of
alternative exon and 3’UTR choice is required for axon growth and neurodevelopment. In human neurons, the
functional roles of specific exon-3’UTR combinations are unknown. The scope, regulation, and function of such
coordinated events will be investigated in human ESCs differentiated to neurons. Alternative exon to 3’UTR
choices will be quantified using a targeted adaptation of direct RNA sequencing (dRNA-target-Seq) that will
provide not only connectivity of exonic content in full length mRNAs, but also isoform specific polyA tail lengths
and RNA modification information. The factors regulating these coordinated events will be investigated, with an
emphasis on neuronal RNA binding proteins. The functional roles of coordinated RNA processing events will
be interrogated for specific genes, with an initial focus on transcriptional regulation genes. Preliminary work
suggests that exon to 3’UTR coordination occurs for many human genes, including the de novo DNA
methyltransferase DNMT3A. The importance of such RNA processing events and their coordination will be
investigated in ES derived neurons using loss of function approaches. These pursuits will lead to accessible
methods to study regulation of gene expression at the level of full-length mRNAs in diverse systems and single
cells. Studying the function of alternative exon to 3’UTR coordinated events in human ES derived neurons will
enable future investigations of how disease associated sequence variants affect mRNA processing in the
context of full-length transcripts.

Public health relevance
PROJECT NARRATIVE Alternative 3' UTR usage can be coordinated with alternative upstream exon choices to generate full length mRNAs that differ in protein-coding capacity and how they are regulated. This proposal investigates how these choices are coordinated in single cells and tests their function in human neurons.